Effects of Gestational Exposure to Extreme Heat and Heat Vulnerability on Early Life Blood Pressure Trajectories

Research has demonstrated that exposure to ambient extreme heat is associated with increased morbidity and mortality. Extended periods of exposure to high temperatures are associated with causing conditions such as heat exhaustion, heat cramps, and heat stroke as well as exacerbating existing conditions including those related to the respiratory, cerebral, and cardiovascular systems. There is little research, however, on the relationship between heat exposure and cardiovascular health (CVH), especially among children. Further, research has not investigated how the vulnerability of neighborhood built and social environments to ambient heat may attenuate such a relationship. This study will address the gaps present in the literature by examining how extreme heat exposure is associated with blood pressure, a key indicator of CVH, during early childhood. It will also explore how neighborhood heat vulnerability acts as both an exposure impacting CVH and a modifier on the pathway between heat exposure and CVH. To do so, this study will leverage data from a regional birth cohort with follow-up through early childhood which will be linked to validated, national data for ambient, built, and social environmental exposures. In Aim 1, I will describe trends of how gestational extreme heat event (EHE) exposure and neighborhood vulnerability are distributed across the study area and by sample sociodemographic characteristics. In Aim 2, I will investigate associations between gestational EHE and blood pressure outcomes throughout early childhood. Finally, in Aim 3, I will investigate the role of gestational heat vulnerability with EHE and blood pressure. This study will advance our understanding of the mechanisms by which environment can affect CVH. This will inform future interventions and policy to reduce CVH morbidity from a growing public health threat during a sensitive period of life when prevention may be most effective.

Public health relevance
There are significant gaps in our understanding of how exposure to high temperatures affects cardiovascular health during childhood, and how neighborhood vulnerability to heat may modify this exposure. This study will use epidemiologic and geographic data to identify the relationships between extreme heat exposure, neighborhood heat vulnerability, and early childhood blood pressure. The results of this study will inform future interventions related to heat exposure and the development of cardiovascular disease during early life.